Clinical Prediction Tools for Head and Neck Cancers

A growing number of clinical prediction models (CPMs) have been developed to provide
individualized estimates of the risk of various clinical outcomes, including mortality (or
survival), for cancer patients. By utilizing patient, disease, and treatment characteristics
to estimate these outcomes at the individual—rather than aggregate—level, these CPMs
produce the critical evidence that patients and clinicians need to make rational,
personalized decisions about cancer treatment. The individualized risk information
produced by CPMs thus holds great promise for improving the quality of cancer care.

The clinical implementation and dissemination of CPMs in cancer care, however, faces a
critical challenge. Existing CPMs are each limited in their focus. Some CPMs estimate
mortality risk conditional on cancer patients’ comorbidities without adjusting for the
treatments they undergo, while numerous other CPMs focus on mortality risk conditional
on patients’ particular treatments, but irrespective of comorbidities. For example,
separate CPMs have been developed to estimate mortality risk of clinically localized
prostate cancer following radical prostatectomy and conservative treatment; however,
these models do not account for comorbidities, and no CPMs estimate mortality risk
following radiation therapy. Hence, there is no single CPM that can support most clinical
decisions related to cancer management even for a single cancer site.

The Surveillance, Epidemiology, and End Results (SEER) Program is one of the premier
cancer surveillance programs in the world currently composed of population-based cancer
registries covering 30% of the total US population. The information collected on each and
every cancer patient in SEER coverage areas includes demographics, a description of
their cancer, treatment, and patient follow-up including cause of death for deceased
patients. Periodic reports on various aspects of the cancer burden on the population
including incidence, survival, treatment, and mortality using the SEER database are made
available to the general research community and the public and are routinely cited in the
medical literature and the media. In most statistical reports on cancer provided by SEER
in the past, information on survival has been net survival, i.e., survival which reflects the
likelihood of dying of causes related to a patient's cancer in the absence of competing
causes of death and is of limited value to clinicians and patients because it does not
reflect a patient's actual survival experience. An initiative of the SEER Program has been
to utilize the high-quality patient follow-up data (that SEER has collected since its inception
in 1973) for the purpose of creating statistical tools that provide survival information that is
more clinically relevant to physicians and individual patients. The approach taken was to
develop the SEER*Cancer Survival Calculator (SEER CSC) which will include algorithms
or nomograms for various cancers that will provide survival statistics that account for
competing causes of death including the crude probabilities of dying from cancer and from
other causes along with the probability of survival. These probabilities are provided in
response to inputting a profile of prognostic variables for a patient. One unique aspect of
the SEER CSC is the "life expectancy in the absence of cancer” which is derived from
Medicare data linked to SEER and quantifies how much longer someone is expected to live
if they did not have their cancer.

The purpose of this agreement is to work with the Veterans Administration to further revise
and refine the SEER*CSC module for oral cancer, the language and structure of which we
now also plan to use as a model for the other cancers the CSC is addressing. SEER*CSC
was originally developed with the idea that it would just be released for health care
professionals, but after substantial discussion over the past several years, it was determined
that it will be released on a public website for use by patients and their families. This has
required new revisions to make the language and overall format more accessible to a general
audience and making appropriate disclaimers so that people will not use the calculator for
inappropriate purposes. Work involves discussions with head and neck patient advocacy
groups which will lead to refinements to the user interface for the entire SEER*CSC program
(to include visual aids, for example) to accurately place it in the landscape of other prognostic
tools, ensuring the information links to correct deeper level information about cancer statistics
and interpretation more broadly, and revising the academic paper summarizing the
development of the oral cancer module, and its use in a general public setting. This work is of
great import to the VA, because Veterans are disproportionately affected by head and neck
cancer compared to other populations in the U.S. In addition, as a relatively rare cancer, the
power of case capture by the NCI makes them an ideal partner for this kind of work, which
could not be carried out by the Department of Veterans Affairs alone - there are not enough
cases or a record keeping system in the VA to easily create the models that are needed to
make these sorts of complex calculations.